Development of a Novel Couples-Based Suicide Intervention: Treatment for Relationships and Safety Together (TR&ST)

Background: Suicide is one of the leading causes of death in the United States and worldwide, with suicide
rates among U.S. military veterans doubling (27.7 per 100,000) the rate of civilian levels (14.7 per 100,000).
Despite a rise in prevention efforts, rates have continued to increase. Theories of suicide and rehabilitation
psychology stress the importance of the person-environment interaction in contributing to one’s disability
experience. Specifically, research has consistently found that the most frequent precipitant of suicide is a
problem with a romantic partner. Conversely, people with better relationship functioning are less likely to have
suicidal thoughts. The International Classification of Functioning, Disability and Health (ICF) identifies social
engagement and communication as important components of functioning. Prevention of suicide in at-risk
veterans is of vital importance and the quality of one’s intimate relationship is an understudied intervention
target for suicide prevention. This proposal refines and evaluates preliminary efficacy of the first couples-based
suicide-specific intervention—Treatment for Relationships and Safety Together (TR&ST).
Significance/Innovation: Suicide prevention is the top clinical priority for VA/DoD. The importance of including
family members in Veterans’ suicide-related care is a critical component of the National Strategy for Preventing
Veteran Suicides 2018-2028 and key finding from VA/DoD patient focus groups conducted for the 2019
VA/DoD Clinical Practice Guidelines for the Assessment and Management of Patients at Risk for Suicide.
Innovative aspects of this CDA-2 proposal directly address several components of national reports and include:
1) The first couples-based suicide-specific intervention and the first suicide-specific intervention to target
interpersonal functioning factors identified by suicide theories and rehabilitation psychology (i.e., effective
communication and interpersonal engagement); 2) Veteran-centric choice between home-based telemental
health and office-based care in order to increase access; and 3) Improved data analytic quality of Veteran
suicidality by examining both Veteran and partner reports of suicide related risk factors (the first suicide-
specific treatment study to do this).
Methodology: The proposed 5-year study consists of two phases. Phase 1: treatment refinement with 10
couples (N=20) and Phase 2: pilot Randomized Controlled Trial (RCT) of TR&ST compared to VA Standard
Suicide Intervention with 60 couples (N=120). The intervention period is 13 weeks and the entire study period
is approximately 7 months. Couples in both phases will be quantitatively assessed at baseline, mid-treatment,
post-treatment, and 3-months post-treatment (and qualitatively interviewed following each TR&ST module).
The primary outcome to be evaluated is change in suicidal ideation severity. Secondary outcomes concern
changes in interpersonal functioning.
Aims: Aim 1 (Phase 1): Refine TR&ST in a population of Veterans with active suicidal ideation. Aim 2 (Phase
2): Evaluate treatment feasibility and acceptability of TR&ST. Aim 3 (Phase 2): Compare TR&ST vs. VA
Standard Suicide Intervention on suicidal ideation severity and interpersonal functioning (i.e., communication,
bonding, relationship satisfaction, and belonginess and burdensomeness) over 7 months.
Next Steps: This Career Development Award is the first step toward developing a vital program of research
within VHA focused on enhancing interpersonal functioning and suicide-related care by involving family
members in treatment. If Aims are achieved, future work includes 1) an adequately powered RCT of TR&ST
vs. VA Standard Suicide Intervention 2) a more direct evaluation of telehealth for couples-based or family
involvement in suicide-specific interventions, and 3) examination of moderators or groups of interest (such as
women Veterans).

Public health relevance
Suicide prevention is the top clinical priority for VA/DoD and despite VA/DoD recommendations to include family members in suicide related care, there is currently no couples-based suicide-specific intervention. Suicide theories and rehabilitation psychology highlight the importance of healthy interpersonal connection, and research has found that suicidality and relationship functioning are intimately tied. Including a relationship partner in suicide related care has the potential to enhance treatment outcomes and save Veteran lives. This CDA-2 proposal will refine and pilot the first couples-based suicide-specific intervention–Treatment for Relationships and Safety Together (TR&ST) –and examine acceptability, feasibility and preliminary efficacy for a larger Randomized Controlled Trial. This Career Development Award is the first step toward developing a vital program of research within VHA focused on enhancing interpersonal functioning and suicide related care by involving family members in treatment.